International Federation of Placenta Associations

This application seeks renewal of funding to cover travel costs to allow the attendance of 8-12
trainees and new investigators from the USA at the annual International Federation of Placenta
Associations (IFPA) meetings together with funding to support the travel costs of a senior US-
based investigator to these meetings where he/she will present an invited plenary lecture and
take part in workshop sessions. The many physiologic roles fulfilled by the human placenta in
support of fetal growth and development means that placental research is truly multidisciplinary
and meetings of the placental research community bring together clinicians, translational and
basic scientists of various specializations. Often these are individuals whose primary focus is
not the placenta but who recognize that their talents can be brought to bear on investigations in
this most multifaceted area. The highly successful annual IFPA meeting has served to bring
together clinicians and scientists, established senior, mid-career and junior investigators from
around the world, to report and discuss their findings in an atmosphere conducive to frank yet
amicable exchange. Meetings are scheduled in September/October of each year in Buenos
Aires, Argentina (2019), Amsterdam, The Netherlands (2020), Rotarua, New Zealand (2021),
Montreal, Canada (2022), Europe (2023) and Japan (2024). The meeting duration is 3 - 3 1/2
days with up to eight plenary sessions addressing specific aspects of placental function. The
main speaker in each plenary gives a state of the art presentation and is not necessarily a
placental biologist. Plenary sessions are accompanied by a corresponding interactive 2-hour
workshop session addressing controversial questions. At least two 3-hour poster discussion
sessions are scheduled and posters are displayed for the entire meeting to allow time for in
depth discussion of work particularly of new investigators. Oral sessions for new investigators
and trainees are scheduled with the best abstracts selected for these by the program
committee. Prizes are awarded for the best oral presentation and best poster presentations by
trainees or new investigators. Trainees and new investigators will be selected based on
competitive review of submitted first author abstracts for award of travel funds. The US–based
senior investigator will be selected by the meeting organizer and PI of this proposal.
There is always a high proportion (up to 60%) of women attendees, speakers and session
chairs at IFPA meetings ensuring adequate representation. In the last 14 years a previous
conference grant (PI: Myatt) has supported 121 young investigators of whom 89 were female
and 37 minorities. A significant majority are still engaged in the field.

Public health relevance
The highly successful annual International Federation of Placenta Associations (IFPA) meeting serves to bring together clinicians and scientists, established senior, mid-career, and junior investigators from around the world, to report and discuss their findings in an atmosphere conducive to frank yet amicable exchange. In addition, the IFPA meetings include interactive sessions on career development, and networking opportunities. This application seeks funding to cover travel costs to allow the attendance of 8-12 trainees and new investigators from the USA at the annual IFPA meetings together with funding to support the travel costs of a senior US-based investigator to these meetings where he/she will present an invited plenary lecture and take part in workshop sessions.